Developing Immunogens to Elicit Broadly Neutralizing anti-HIV-1 Antibodies

Project Summary
The Administrative Core (Core B) will provide administrative leadership and effective project
management for this HIVRAD Program Project. Core B will oversee scientific progress relative to
project aims and milestones and lead scientific efforts in conjunction with the Scientific Advisory
Board. It will coordinate financial management, research program management, regulatory
compliance, and reporting functions. In addition to coordinating these activities, the Administrative
Core will be responsible for promoting and documenting all aspects of scientific, regulatory, and
financial compliance at Caltech and the subcontracting institutions. Dr. Pamela J. Bjorkman will
serve as the Core Leader, with staff located within her administrative office as well as those of
Vielmetter, Hahn, Shaw, and Nussenzweig, thus comprising a highly experienced and
integrated management team. The Administrative Core will 1) Organize and govern the HIVRAD
Program Project and 2) Coordinate the interactions between the three Projects and with the
broader scientific community. This includes arranging formal communications among
investigators, preparing protocol submissions and annual renewals to the Institutional Animal
Care and Use (IACUC) committees, coordinating material transfer agreements, preparing reports
and manuscripts, monitoring budgets, planning annual meetings and monthly conference calls,
maintaining the HIVRAD website, and generally overseeing the scientific and administrative
needs of the Program Project. In addition, the Administrative Core staff will assist in the effective
sharing of data by maintaining shared cloud-based notebooks and databases and ensure that the
NIH Data Management and Sharing Plans are implemented.